State of the Brain

? DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled State of the Brain, organized by Terrence J. Sejnowski and Sten Grillner. The meeting will be held in Alpbach, Austria from May 22-26, 2016. Recent years have seen rapid advances in our understanding of brain biology, driven in part by the development of novel technologies for studying neural networks. Consequently, major national research programs in the EU and US have been launched that will bring together teams of neuroscientists and engineers with the aim of achieving a major advance in understanding brain function and dysfunction. The challenge is to map the circuits of the brain, measure the fluctuating patterns of electrical and chemical activity flowing within those circuits and understand how they give rise to cognitive and behavioral capabilities. This Keystone Symposia conference brings together investigators from around the world to share their discoveries and to plan future projects in this exciting new era for brain research.

Public health relevance
PUBLIC HEALTH RELEVANCE: The human brain is the source of our thoughts, emotions, perceptions, actions, and memories; it confers on us the abilities that make us human, while simultaneously making each of us unique. Over recent years, neuroscience has advanced to the level that we can envision a comprehensive understanding of the brain in action, spanning molecules, cells, circuits, systems, and behavior. We are at a unique moment in the history of neuroscience-a moment when technological innovation has created possibilities for discoveries that could, cumulatively, lead to a revolution in our understanding of the brain. The 2016 Keystone Symposia conference on State of the Brain will bring together investigators from around the world to share their discoveries and to plan future projects in this exciting new era fo brain research.